VASCULAR FUNCTION IN PATIENTS WITH EXCESSIVE GRAVITATIONAL POOLING

This study was designed to determine the pathophysiological abnormality in patients with orthostatic hypertension. Methods will include measurement of arteriolar responsiveness to norepinephrine, determination of alpha-2 adrenergic receptor function by binding of triatiated yohimbine to platelets, and in vitro responsivenesss of segments of excised saphenous veins to norepinephrine.